Adolescent-tailored HIV treatment and prevention strategies in South Africa: projecting clinical benefits and value (Supplement)

PROJECT ABSTRACT
With the increasing demand for and emerging data regarding long-acting injectable (LAI) antiretroviral therapy
(ART), there is a growing need to understand its impact on and potential among adolescents and young adults
(AYA), a group with historically low adherence to oral ART and high risk of virologic failure. Despite promising
new data on long-acting cabotegravir and rilpivirine's (LA-CAB/RPV) efficacy and safety, critical questions
remain about its long-term effectiveness and the risks associated with prior low adherence. The AFINAty study
addresses these gaps by investigating the effectiveness and feasibility of LA-CAB/RPV in AYA in Cape Town,
South Africa. The AFINAty study team has unexpectedly acquired two additional years of study drug (from
Johnson and Johnson) providing us with the serendipitous and unforeseen opportunity to obtain new data on
virologic suppression, drug concentrations and genotypes within the study cohort. By integrating these findings
into a validated computer simulation model, we aim to project the clinical and economic impact of incorporating
baseline genotypic information into clinical decision-making. This comprehensive analysis will provide
actionable insights into optimizing LA-ART usage, enhancing adherence and clinical outcomes for AYA with
HIV. Ultimately, the study will inform global HIV treatment strategies and improve long-term health outcomes
for this understudied population.
Supplement Aim 1. To collect and analyze predictors of durable virologic suppression in the AFINAty cohort,
including both drug concentrations and genotypic information.
Supplement Aim 2. Using the CEPAC-AYA simulation model, to determine the clinical impact, cost and cost-
effectiveness of baseline genotyping vs. clinical history to inform LA-CAB/RPV selection among individuals
who are virologically suppressed and initiating this treatment modality.
Our overall objective is to leverage a critical opportunity to understand viral suppression, drug concentration
and genotypic data over a three-year period among AYA in AFINAty. These data are not available anywhere in
the world, and will add tremendous value to the parent grant, consistent with its originally approved objectives.

Public health relevance
PROJECT NARRATIVE To date there is no access to long-acting injectable (LAI) antiretroviral therapy (ART) – specifically long-acting cabotegravir and rilpivirine (LA-CAB/RPV) – in low- and middle-income countries outside of research studies. Our overall objective is to leverage a critical opportunity to determine the clinical and economic value of viral load, drug concentration and genotypic data in making clinical treatment decisions amongst adolescents and young adults in South Africa who would benefit from LA-CAB RPV. Understanding the durable value of LA- CAB/RPV among adolescents – and which adolescents would benefit most from this intervention – will be critical to convey to policymakers and international organizations negotiating for access as well as to global treatment strategies.